Patch-based deep scRNA-Seq to understand axon repair in the mammalian spinal cord

Project Summary / Abstract for the parent award R01NS139527
Traumatic spinal cord injury is a devastating condition that affect about 302,000 people in the United States,
with 18,000 new cases each year. The limited ability of axons to regenerate after injury in the adult central
nervous system (CNS) underlies the permanent functional deficits and paralysis experienced by people with
spinal cord injury. Much research remains to be done to fully understand how regeneration is controlled by
molecular and cellular machinery in the neurons. This proposal builds on our recent success of applying Patch-
based single cell RNA sequencing technology to interrogate the molecular mechanism of corticospinal axon
regeneration after spinal cord injury. By sequencing only hundreds of neurons but at unusually high depths,
we developed a regeneration classifier that can be broadly applied to predict the regenerative potential of
diverse neuronal types based on their single cell profiles, the first of its kind in regenerative biology.
Furthermore, this study implicates key components in mitochondrial biogenesis and antioxidant response in
regulating regeneration. Here we propose to expand Patch-seq based single cell RNA sequencing approach
in several ways. First, we will refine and extend the regeneration classifier by sequencing additional
corticospinal neurons and other neuronal types with different regenerative capabilities. This will allow us to
develop a more accurate regeneration classifier and understand its full range of capabilities and limitations.
Second, we will investigate the role of antioxidant response and mitochondrial biogenesis with a comprehensive
array of genetic gain and loss of function analyses on NFE2L2 and PPARGC1A, master regulators of the two
biological processes and two top candidates from our Patch-seq study. Third, we will conduct deep sequencing
on young versus old neurons to understand the age impact on axon regeneration, which would be required to
develop therapies that are robust across age groups. Together, the proposed experiments using this unique
deep single cell RNA sequencing approach will bring a greater understanding of the neuron intrinsic control of
axon regeneration, providing the foundation for therapeutic development to promote repair and recovery after
spinal cord injury.

Public health relevance
PROJECT NARRATIVE Promoting axon regeneration remains an important strategy in order to identify effective restorative treatment for spinal cord injury. This proposal will using a cutting-edge experimental approach, Patch-seq, to better understand the neuron intrinsic control of regenerative process. New insights gained will be valuable in designing therapies to promote repair and recovery after spinal cord injury.